Dosing and Pilot Efficacy of 2'-Fucosyllactose in Inflammatory Bowel Disease

The Inflammatory Bowel Diseases (IBD), Crohn Disease (CD) and Ulcerative Colitis (UC), are chronic and
debilitating disorders with peak incidence in the second and third decades of life. While considerable progress
has been made in optimizing medications to achieve remission, relapse is common and unpredictable. Altered
microbiota likely drive gut inflammation and clinical relapses. Microbiota-accessible dietary carbohydrates
with beneficial health effects, known as “prebiotics,” hold promise for restoring healthy gut microbiota in IBD
and preventing clinical relapse. Here, we propose the first studies of the prebiotic human milk oligosaccharide,
2’-fucosyllactose (2’-FL), for maintaining remission in IBD. Our overarching hypothesis is that 2’-FL
supplementation in IBD will be safe and well tolerated, while increasing fecal Bifidobacterium abundance and
butyrate in a dose dependent manner. We will test this hypothesis by conducting a randomized, placebo-
controlled dose-ranging study and completing the following Aims: Aim 1. Define dose dependent safety and
tolerability of 2’-FL as a dietary supplement in IBD. We will test 1, 5, or 10 gm 2’-FL compared to 2 gm
glucose placebo as a daily dietary supplement in pediatric and young adult IBD patients in stable remission
receiving infliximab or adalimumab anti-TNF therapy. Safety and tolerability will be assessed using validated
clinical disease activity indices, a novel electronic symptom tracker, and fecal calprotectin. Aim 2. Define
dose dependent efficacy of 2’-FL as a dietary supplement in IBD. We will utilize our established fecal
metagenomic, metatranscriptomic, and metabolite assays to test the effect of a range of 2’FL doses upon the
gut microbial community and associated metabolic functions with a focus upon butyrate production. Efficacy
will be assessed by determining the dose dependent effect of 2’-FL upon increased fecal Bifidobacterium and
butyrate abundance. We will account for FUT2 secretor status in the analysis. These studies will have a high
impact in the field by providing critical phase I/IIa safety and efficacy data in support of a phase III RCT using
our NIH-supported IBD clinical research network to test the efficacy of 2’-FL in directly modulating beneficial
microbiota and thereby enhancing sustained clinical remission. Ultimately the proposed studies will promote a
fundamental shift in clinical practice towards personalized microbial therapeutic interventions.

Public health relevance
Altered microbiota drive mucosal inflammation and clinical relapses in patients with Inflammatory Bowel Disease (IBD). We will conduct the first studies of the prebiotic human milk oligosaccharide, 2’-fucosyllactose (2’-FL), for enhancing beneficial microbiota and associated metabolites in IBD patients. These studies will have a high impact in the field by providing critical phase I/IIa safety and efficacy data in support of a phase III randomized-controlled trial to test the efficacy of 2’-FL in directly modulating beneficial microbiota and thereby enhancing sustained clinical remission.